Extreme weather-related events and environmental exposures in the risk for Alzheimer's disease and related dementias

PROJECT SUMMARY
The 2018 National Institute on Aging AD Research Summit recommendation of “Understanding the
Impact of the Environment to Advance Disease Prevention” as a key strategic plan to treat and
prevent Alzheimer's Disease and related dementias (ADRD) by 2025. Exposure to extreme
weather-related events, air pollution, and environmental contaminants are pervasive, yet little is
known about their relationships with ADRD, especially among a diverse older population. The
proposed study addresses critical gaps in the literature by linking residential history on a diverse
sample of over 3,379 individuals from 3 ongoing NIH-funded cohort studies (Kaiser Healthy Aging
and Diverse Life Experiences (KHANDLE, n=1712, mean age 76.2, 71% non- White), the Study of
Healthy Aging in African-Americans (STAR, n=764, mean age 68.4, 100% non-White) andLife After
90 (LA 90, n=903, mean age 92.7, 72% non-White)) to newly collected data on environmental
exposures and will generate new granular, comprehensive, lifecourse measures of environmental
exposures that will be used to examine their association with ADRD. All studies conduct
harmonized neurocognitive assessments, clinical exams and neuroimaging, collect information on
lifecourse risk factors, and are linked to health data (1960s-1990s) and electronic medical records
(1996-present). Residential history at seven time points is collected (birth-current), and will be
geocoded and linked to historic exposure data. The overall objective of this studyis to investigate
exposure to extreme weather-related events, air pollution, and toxic environmental contaminants on
cognitive function, ADRD, and neuroimaging biomarker in diverse aging populations. In a unique
and unprecedented opportunity to comprehensively evaluate environmental exposures on late-life
brainoutcomes, this study will address the following among 3,379 diverse Northern California
residents: (1) Test the associations between exposure to extreme weather-related events (extreme
heat, drought, wildfire) on neuroimaging markers, cognitive decline, and ADRD; (2) Determine the
associations between exposure to ambient particulate air pollution (fine and ultrafine particulate
matter (PM2.5, PM0.1)) on neuroimaging markers, cognitive decline, and ADRD; and (3) Assess the
relationships between exposure to toxic environmental contaminants (lead, mercury) on
neuroimaging markers, cognitive decline, and ADRD. Leveraging cumulative and time-dependent
exposure to these environmental factors will illuminate lifecourse period in which exposureto these
environmental factors is especially salient to healthy brain aging. Findings from this study have the
potential to uncover new risk factors for ADRD and cognitive decline, and provide targets of ADRD
interventionthat would improve healthy brain aging for people of all racial/ethnic groups.

Public health relevance
PROJECT NARRATIVE Identifying environmental factors related to Alzheimer's disease and related dementia (ADRD) risk is critical to reducing the burden of ADRD and is recommended by the 2018 National Institute on Aging AD Research Summit recommended. We propose to link geocoded residential history from a large diverse sample with newly collected data on (1) extreme weather events, (2) ambient particulate air pollution, and (3) toxic environmental contaminant exposures, to identify environmental exposures linked to ADRD, examine how these exposures are distributed across different racial/ethnic groups and across the lifecourse, and identify timing in the lifecourse during which these exposures are especially salient to ADRD and late-life cognition. Findings from the study may provide targets of ADRD intervention that would improve healthy brain aging for people of all racial/ethnic groups.